Enhancing Biomedical Engineering, Imaging, and Technology Acceleration (BEITA) at North Carolina Central University

North Carolina Central University (NCCU) is well-positioned to develop talent in biomedical engineering and technology through its research institutes and a nine-year-old Fabrication (Fab) Lab that promotes makerspace activities. The Fab Lab's collaborations across departments have highlighted the need for more opportunities in bioprinting technology. This proposal will expand the Fab Lab into a biotechnology makerspace with advanced bioprinting and imaging resources. By equipping students and researchers with hands-on experience in bioprinting technologies, NCCU will strengthen its role as a supplier of biotechnology talent in the global marketplace. The specific aims (SA1) are to develop a Biomedical, Imaging, and Technology Acceleration (BEITA) Program framework. The UG3 phase will leverage the existing biomedical research infrastructure at NCCU to plan and develop the BEITA program including (a) a BEITA infrastructure framework; (b) a management plan with an impactful scientific growth strategy; (c) an Advisory Committee; (d) an Evaluation framework for assessment; (e) engagement and outreach across NCCU and collaborating institutions. The UH3 phase will expand BEITA with engagement and evidence-based improvement of the program. SA2: Develop Infrastructure and Promote Research Applications Through Bioprinting, Imaging, and Technology Advancement. The acquisition, training and management of state-of-the-art equipment and research for bioprinting technologies will facilitate the transition of research from traditional models to innovative, 3-dimensional models, which better represent human tissues. We will provide advanced imaging tools and standard protocols including utilization of artificial intelligence toward building a 3D bioprinting hub at NCCU and collaborating institutions. In the UH3 phase, we will further expand the maker space to support biofabrication, imaging, analysis, and material testing, managed by trained personnel. SA3: Develop Education and Training Programs in Biomedical Engineering and Technology. In the UG3 phase we will implement curriculum enhancement and informal training opportunities at all levels, including dual degree programs with R1 institutions, presentations, and publications. We will develop research practicum in bioprinting technology development leveraging BEITA at NCCU to provide experiential learning and partnerships with RTP biotech companies, corporate projects, internships, and career placement. The long-term outcomes include integration of BEITA into the institutional academic fabric through enhancement of research infrastructure and development of a sustainable pipeline of NCCU graduates with advanced degrees in biomedical engineering.

Public health relevance
Project Narrative Our program builds upon the strengths of North Carolina Central University (NCCU), a top Historically Black College or University in the heart of Durham, NC, adjacent to world-class institutions and a booming biotechnology hub. The program will build research capacity centered on bioprinting and imaging approaches, with applications in many fields, including tissue engineering, materials science, pharmaceutical development, and drug validation. The outcomes will provide experiential learning opportunity, an enriched curriculum at both undergraduate and graduate level and bridge NCCU trainees to biomedical engineering, imaging, and technology acceleration fields.